Improving Affordability in Cancer Care through Economic Screening and Support (I-ACCESS)

Abstract
Improving Affordability in Cancer Care through Economic Screening and Support (I-ACCESS) is a proposed
screening assessment and referral program to proactively identify cancer-related financial hardship in patients
with cancer at diverse clinical settings and connect those at-risk with education, counseling, and resources.
The objective of this study is to pilot and refine I-ACCESS across diverse clinical practice settings to yield a
process that directly aligns with consensus standards of care and practice guidelines to assess patients for
financial hardship and provide financial resources and support. In Aim 1, we will characterize the context of the
context of geographically and demographically diverse clinical practice settings to prepare for I-ACCESS
implementation through interviews with up to 30 clinical leaders and frontline staff. Assessment constructs will
focus on understanding structural characteristics (including information technology infrastructure), available
resources, culture, compatibility, relational connections, communications, and access to knowledge. These
data will inform the creation of tailored process maps to outline processes and procedures to prepare each site
for I-ACCESS implementation and elucidate when, how, and by whom I-ACCESS screening should be done.
In Aim 2, we will implement I-ACCESS and determine the effectiveness of the screening tool in facilitating
patient referrals for financial hardship counseling. Using a pre-/post-approach, we will examine whether I-
ACCESS screening increases the number of financial counseling and oncology social work referrals (primary
outcome) within two large healthcare systems and a network of community-based practices. We will also
examine counseling dispositions, receipt of services among those referred to financial support, and the
predictive accuracy of the screening tool (secondary outcomes). In Aim 3, we will assess the implementation of
I-ACCESS across diverse clinical practice settings using a sequential mixed-methods, multi-stakeholder
evaluation. Informed by the Practical, Robust, Implementation and Sustainability Model (PRISM) framework,
we will analyze approximately 225 patient and 25 clinician surveys to gather feedback on I-ACCESS delivery,
procedures, and barriers/facilitators to implementation. Based upon survey findings, we will then focus on key
implementation determinants and outcomes through in-depth, semi-structured interviews with up to 40
stakeholders. Stakeholders will include patients, caregivers, healthcare providers, financial counselors, clinical
support staff, and hospital administration at participating clinical sites. Findings from this study will inform future
large-scale, multi-site hybrid effectiveness-implementation research to assess the scalability of I-ACCESS
across care delivery settings and its integration with ongoing care.

Public health relevance
Project Narrative Cancer-related financial hardship occurs frequently among patients and survivors, and it is a key driver of inequities in access to care and disparities in treatment outcomes. Yet, there is limited research into interventions, particularly those at the hospital-level, to prevent and mitigate financial hardship. The proposed study aims to to implement and evaluate a systematic approach to screening patients with cancer for risk of financial hardship and connecting them with financial counseling.